An LCMS-guided bioanalytical approach for rational natural product library design and optimization

Project Summary/Abstract
Natural products are a mainstay of drug discovery, accounting for up to 50% of approved drugs either as
direct natural molecules or as inspiration for synthetic molecules. High-throughput screening of compound
libraries is a common starting point for drug development campaigns. The quality of these libraries is therefore
a key determinant of high-throughput screening campaign success. Natural product compound library design is
particularly challenging given redundancies in natural product production between isolates and greater costs of
compound production and isolation. Evidence-based and scientifically rigorous methods to optimize
natural product library design are therefore urgently required. In MPIs’ previous work, they demonstrated
using the example of the fungus Alternaria that liquid chromatography-tandem mass spectrometry (LC-
MS/MS)-based analysis of fungal extracts could reveal the minimal number of extracts to include in a chemical
library, to achieve saturation of chemical diversity. Strikingly, this number could be as small as 39 isolate
extracts, depending on the Alternaria clade. It is now necessary to demonstrate the broader utility of this
bioanalytical approach, to the significant biological problem of high-throughput screening natural product
chemical library design. In addition, the high-throughput nature of our approach enables the systematic and
unbiased assessment of different natural product diversification approaches on elicited chemical diversity. Our
proposal builds on MPI’s extensive expertise in metabolomics and small molecule characterization and natural
product analysis. In addition, it is enabled by the MPI’s access to the large collection of fungal isolates from the
University of Oklahoma Citizen Science Soil Collection Program. This collection currently totals >78,000
isolates from 893 fungal genera. Our central hypothesis is that our untargeted metabolomics method can
be applied to generate specific rules of natural product library design and provide evidence to prove or
disprove current dogma governing natural product library design. We will focus on three common library
design approaches, in three independent aims. Aim 1 will focus on using our approach to demonstrate that
comparable chemical diversity can be obtained from focused, rationally-designed natural product libraries,
compared to random serendipitous discovery. Aim 2 will systematically assess the impact of co-culture on
elicited chemical diversity, comparing sympatric vs allopatric co-culture systems. Aim 3 will systematically
quantify the impact of environment-mimicking culture conditions such as soil or bacterial-derived signals, on
elicited chemical diversity. Overall, our results will lead to validation of a new approach for rational natural
product library design, with major implications for drug development.

Public health relevance
Project Narrative High-throughput screening of compound libraries is a fundamental starting point to drug development efforts, and natural product libraries are one of the most valuable sources of novel bioactive molecules. However, until now there have been few evidence-based rules for the rational design of natural product libraries. This work is relevant to public health because it will demonstrate the utility of bioanalytical liquid chromatography-mass spectrometry to addressing this biological need, and lead to accelerated drug development in the long term.